Circuit mechanism of pheromone processing and innate behavior

Project Summary/Abstract
Animals have evolved specialized neural circuitry that links sensory input to neuroendocrine and behavioral
responses. The proper function of these systems is essential for the health and wellbeing of individuals.
Sensory inputs controls some fundamentally important innate behaviors, including mating, aggression and
parental behaviors. Dysfunction in these circuits may lead to depression, mood disorders, sexual dysfunction,
and aberrant parental behaviors. Here we propose to study the neural circuits that detect and process
pheromone information and regulate endocrine and behavioral responses in rodents. In vertebrates,
pheromone cues can directly trigger mating rituals and territorial aggression. Many terrestrial species have
evolved highly sophisticated vomeronasal systems to detect pheromones. The vomeronasal circuit connects
directly to the endocrine systems and influences their output. These circuits are largely genetically determined
and there is an intrinsic link between sensory input and the behavioral responses. The mouse vomeronasal
circuitry, therefore, serves as an ideal model system to elucidate the neural mechanism of sensory information
processing, mechanism of neuroendocrine control and sensory control of innate behaviors. Similar circuits
exist in humans but may have been compacted during primate evolution to consist of mostly the main olfactory
system, and to include other sensory modalities. The study of the vomeronasal system can provide a roadmap
to understand these more complex circuits.
The objective of this application is to delineate the vomeronasal circuitry that detects and processes
information of two classes of female pheromones. The proposal is based on our study identifying two sets of
vomeronasal receptors recognizing pheromones cues that convey the sexual identity and the estrus status of
female mice, respectively. In this study, we will determine the contribution of vomeronasal sensory neurons
(VSNs) expressing these receptors to sexual behaviors. We will investigate and determine the connectivity
diagram between the VSNs and the mitral cells in the accessory olfactory bulb. We will also identify the brain
regions and specific cell populations that process information conveyed by these cues and map their
connections. These studies are expected to reveal highly specific neural circuits that control mating behaviors

Public health relevance
8. Public Health Relevance. Social communications are critically dependent on the proper processing of social information. The social cues detected by the sensory systems can induce neuroendocrine responses that control multiple aspects of the nervous system and elicit innate behaviors. The proper function of these systems is crucial to the health and wellbeing of human beings. Malfunction of these sensory systems that result in the improper processing of sensory information can lead to deficit in cognitive function and psychiatric disorders. By investigating the neural circuitry that mediates social communications among animals, which has a direct influence on the endocrine control of reproductive and aggressive behaviors, we will be able to elucidate the functional logic of the circuit and provide insights into the brain mechanisms of processing sensory information, mediating social communications, and exerting endocrine control. This knowledge can be used for diagnostic and therapeutic applications.